Genetic Characterization of phosphomannan biosynthesis in C. auris

Candida auris is a recently emergent fungal pathogen. This newly emergent species has risen worldwide over
the last ten years since its first recognition in Japan.This organism has become a public health problem due to
its antifungal resistance and its ability to persist in critical care and nursing home facilities. One of the reasons
behind this ability to persist is that many of the clinical isolates show multidrug resistance and, in rare cases,
can be pan-resistant. Recently we examined the cell wall of eight C. auris isolates and discovered that C. auris
mannans contain additional mannosyl phosphate (Mα1-PO4) branching that is unique to this species. This is a
very exciting and potentially very important new finding. The fact that C. auris has an outer coating of mannan
that is structurally distinct from all other Candida species and, indeed, any other fungal pathogen, suggests
that the Mα1-PO4 structure distinguishes C. auris from other fungal pathogens. At this point, virtually nothing is
known about the genes which control the expression of this unique cell wall phenotype. In C. albicans the
Mnt3, Mnt5, and Mnn4 proteins are phosphmannosyltransferases responsible for phosphomannan
biosynthesis. In addition there are seven Mnn4-like proteins that are functionally redundant with Mnn4 but do
not play a major role in phosphomannan biosynthesis. A survey of the Candida Genome Database revealed
that C. auris also contains the MNT3, MNT5, and MNN4 genes in addition to five MNN4-like genes. Due to the
similarities of the genes in C. auris to those of C. albicans we hypothesize that the MNT3,MNT5 and
MNN4 genes maintain a conserved role in phosphomannan biosynthesis, while one or more of the five
MNN4-like genes have diverged to produce proteins that impact the Mα1-PO4 branching and/or
phosphorylation. We will assess the role that these genes play via construction of deletion mutants in C. auris
to determine if they impact phosphomannan biosynthesis and the addition of M1α-PO4 branching, using high
field NMR. In addition we will determine if these mutants have increased or decreased attractiveness to
human macrophages and their ability to kill the macropahges. From this work we expect to develop a better
understanding of mannan biosynthesis in C. auris. The data generated will help to serve potential diagnostic
and vaccine development in the future.

Public health relevance
This project will investigate the impact that genes have on the biosynthesis of outer cell wall structure called phosphomannan in the emerging fungal pathogen Candida auris. C. auris is the first fungal pathogen that can be difficult to diagnose, treat (due to antifungal resistance in many isolates) as well as decontaminate from critical care wards and nursing homes. The completion of this project will provide insight in future work for the development of a rapid diagnostic for this organism and possibly aid others in the development of a potential vaccine.